Probe and Target Lysyl oxidases (LOXs) in Cancer

PROJECT SUMMARY
We work at the interface of chemistry and biology. Our research aims to understand how protein post-
translational modifications (PTMs) and the enzymes involved contribute to cancer signaling and immune
regulation, and how these PTMs, enzymes, enzymatic reactions, and related cellular processes can be exploited
for targeted therapy. One of the PTMs that we are specifically focusing on involves protein crosslinking mediated
by Lysyl Oxidase (LOX) family enzymes. LOXs, including LOX and four LOX-like proteins (LOXL1-4), are copper-
and lysine tyrosylquinone (LTQ)-dependent amine oxidases. They catalyze the oxidative deamination of lysine
residues on proteins, leading to the production of highly reactive aldehydes. These aldehydes form cross-
linkages essential for the structural integrity of collagens and elastin within the extracellular matrix (ECM). While
these processes are vital for tissue development, excessive LOX activity is linked to fibrotic and musculoskeletal
diseases and is implicated in nearly all cancer types. LOXs are believed to promote malignant transformation by
increasing ECM component secretion, stabilization, and crosslinking, thereby inhibiting drug and nutrient
diffusion, and effector immune cell infiltration. High LOX expression in pre-malignant tissues and primary tumors
correlates with increased tumor incidence, invasiveness, and poor patient outcomes. LOXs are significantly
upregulated in a subset of solid tumors resistant to chemotherapy, radiotherapy, and immunotherapy, highlighting
their crucial role in cancer pathophysiology and treatment resistance. Despite their importance, significant
research gaps remain: 1) the identification of LOX substrates is limited due to a lack of technologies for profiling
LOX substrate specificity and real-time activity in vivo; 2) there is minimal exploration of LOX functions in cancer
progression beyond ECM remodeling; and 3) there is a scarcity of research on developing selective and effective
LOX-targeting strategies, crucial for improving therapeutic efficacy and safety in cancer treatment. Our research
aims to address these gaps by developing enabling technologies and novel inhibitors or probes to thoroughly
investigate LOXs, exploring their biological functions and assessing their therapeutic potential in combination
therapy. This initiative, spearheading advancements in technology development, biological study, and
therapeutic intervention, is poised to establish a robust foundation for our laboratory's research endeavors for
the foreseeable future.

Public health relevance
PROJECT NARRATIVE LOX enzymes are key players in both health and disease and are implicated in almost all cancer types. Despite their significance, our knowledge of LOX roles remains strikingly limited, with few substrates identified or validated, underexplored functions beyond traditional ECM crosslinking, and a lack of selective and effective LOX-targeting strategies. Our development of a novel chemical toolbox to probe and inhibit LOX enzymes will enable precise investigations of their roles in biological and pathological contexts, while our highly specific inhibitors hold substantial therapeutic promise, potentially enhancing the efficacy of various cancer treatments.